Inflammatory contributions of clonal hematopoiesis to cardiovascular disease

PROJECT SUMMARY/ABSTRACT
Clonal hematopoiesis of indeterminate potential (CHIP) is a common but poorly understood condition that
predisposes asymptomatic individuals to leukemia and cardiovascular disease (CVD) and is associated with
increased mortality. A recently-discovered condition, CHIP is characterized by the acquisition of age-
associated somatic mutations that promote the expansion of specific blood cell populations, or clones, in a
process called clonal hematopoiesis (CH). While CHIP-associated mutations, such as mutations in the
epigenetic regulator Tet methylcytosine dioxygenase 2 (TET2), are frequently observed in leukemia,
individuals with CHIP are at an even greater risk of CVD, including coronary heart disease and early-onset
myocardial infarction, and the mechanisms underlying these cardiovascular manifestations are not well
understood. While loss of Tet2 in hematopoietic cells accelerates atherosclerosis via the secretion of
interleukin-1 (IL-1β) from pro-inflammatory macrophages, inhibition of IL-1 signaling only partially prevents
atherosclerotic plaque formation, suggesting that additional inflammatory pathways contribute to this
pathology. Indeed, our group has demonstrated that hyperactivation of toll-like receptor (TLR) signaling and
downstream pro-inflammatory transcription factors promote CH and that a feedforward loop involving these
pathways in hematopoietic stem and progenitor cells (HSPCs) propagates CH. However, it is not yet know if
these pathways contribute to CHIP-associated CVD and if HSPCs play a direct role in this context.
We hypothesize that the complex inflammatory response in Tet2-deficient CHIP-associated CVD relies on a
pro-inflammatory feedforward loop between HSPCs and multiple mature hematopoietic lineages mediated by
IL-1β, IL-6, and MYD88 signaling and that suppression of established CVD requires downstream inhibition of
these pathways. To investigate this hypothesis, we propose the following specific aims: (1) to interrogate the
inflammatory pathways underlying CHIP-associated CVD and (2) to investigate whether HSPCs and mature
myeloid lineages contribute to a pro-inflammatory feedforward loop in CHIP-associated CVD. The objective of
this fellowship is to determine the inflammatory signaling pathways and hematopoietic lineages underlying
CHIP-associated CVD and to investigate their feasibility as therapeutic targets. To address these aims, genetic
and pharmacologic approaches will be used to dissect the contributions of these pathways and cell types.
Innovative techniques, including single cell-RNA sequencing, flow cytometry, and ultrasound, will be employed
to elucidate the cell-type heterogeneity of CHIP and to monitor translationally-relevant indicators of disease
progression and therapeutic response. The significance of this proposal is the identification of potential
therapies for established CHIP-associated CVD. As patients with CHIP often present with established CVD, a
better understanding of these pathways and the development of therapeutic agents that can effectively
ameliorate established CVD would significantly improve the clinical care of these patients.

Public health relevance
PROJECT NARRATIVE Clonal hematopoiesis of indeterminate potential (CHIP) is a novel, asymptomatic condition that predisposes to the development both leukemia and cardiovascular disease; however, while CHIP appears to be quite common, the mechanisms underlying its pathogenesis are not well understood. This study will investigate the contributions of inflammatory pathways and hematopoietic lineages to CHIP-associated cardiovascular disease and their potential as therapeutic targets. The development of innovative therapies targeting these pathways may enable the treatment of established CHIP-associated cardiovascular disease, which would significantly improve the clinical outcomes of patients with CHIP.